Understanding and Addressing Systemic Factors Influencing the Quality of End-of-Life Care in Older Adults

Older Americans are not all likely to receive high quality end-of-life (EOL) care due to the substantial variations in care quality as well as in goal-concordant care, adequate pain treatment, and palliative care access across organizations and geographic regions. Despite decades of research documenting variation in EOL care quality, there has been little progress in achieving uniform improvement. This is in part due to a failure to recognize organizational and systems-level factors (e.g., education, employment, and healthcare systems) as a root causes of variation in care quality. There is a critical gap in our understanding of how organizational and systems-level factors the life course influences the quality of serious illness care for older adults near the end of life. The objective of this project is to understand and address those factors as they relate to the systems level the quality of care provided near the end of life. I use a research approach that centers mutual learning and collaborative planning with local patients. This project’s career development plan will provide Dr. Elizabeth Dzeng with skills and knowledge in participatory research methods, implementation sciences, clinical trials, leadership in local-academic partnerships, geriatrics, and life course perspectives. A Beeson award will enable her to become an independent investigator in understanding and addressing the role of systems-level factors in EOL care using participatory methods and support her long-term goal of becoming an international research leader in geriatric palliative care. This study will be conducted at the San Francisco Bay Area to enable understanding of the influence of local and organizational histories, policies, and regions on healthcare. Dr. Dzeng has already been establishing local connections and developing her Patient Advisory Board. The first aim of this proposal seeks understand older adults’ experiences with systems-level factors and how these are perceived to influence care near the end of life. The project’s second aim is to examine how individual and organization-level factors influence the quality of care provided near the end of life and assess what enables or prevents improvements within healthcare organizations. The third aim is to refine and test an intervention that connects hospital leaders and local representatives to tailor a co-ordinated care approach aimed at improving the experience of older adults near the end of life. This study is highly innovative because it would be the first study to examine and address organizational and systems-level factors in geriatric palliative care using life course perspectives and participatory research methods. It uses novel interview and participatory methods to examine the multi-level factors that contribute to variation in EOL care. This study is significant because it will develop understanding at a deeper level of end-of-life care varies for patients with different life courses and address this variation through a multi-disciplinary, multi-component intervention. This study will inform a future R01 application for a multi-center hybrid effectiveness-implementation pragmatic trial of an organizational-level protocol intervention to mitigate variation EOL care quality.

Public health relevance
The proposed research is relevant to public health because, despite decades of research aimed at improving the quality of end-of-life and palliative care, there still exist substantial variations in care quality across organizations and geographic regions. This study seeks to understand and address root causes of the variation in end-of-life care using participatory research methods and a life course perspective. This proposed research is relevant to the National Institute of Aging’s mission to improve the health and well-being of older adults because it seeks to understanding how organizational and systems-level factors impact care quality and to design and test the feasibility and acceptability of an intervention to improve end-of-life care for all older adults.